Safety and efficacy of Belatacept in heart transplantation

Project Summary: Although calcineurin inhibitors (CNIs), including tacrolimus have led to excellent 1-year
outcomes in heart transplantation, long-term survival remains limited by cardiac allograft vasculopathy, driven
by donor-specific-antibodies (DSA), and by CNI-associated morbidity, dominated by chronic kidney disease.
Belatacept, a selective costimulation blocker, is FDA approved for use in kidney transplantation as a CNI-
alternative. By inhibiting CD28/CD80/CD86 interactions belatacept prevents activation of both naïve T cell and
T follicular helper cells associated with the development of DSA, but less effectively inhibits memory T cells. In
kidney transplant recipients, this has translated to sustained improvement in kidney function, suppression of
DSA, and improved graft/patient survival, albeit at the cost of more early rejection which has since been
markedly reduced by using a delayed CNI substitution strategy. Building on these findings, we propose a
randomized controlled trial of belatacept in first-time heart transplant recipients, in conjunction with gradual
tacrolimus withdrawal over 9-months to achieve a CNI-free immunosuppressive regimen (with mycophenolate
mofetil and prednisone). We hypothesize that the gradual approach to CNI withdrawal will promote quiescence
in graft-reactive T cells, thereby preventing rejection, inhibiting the development of DSA, and eliminating CNI-
related morbidity, together increasing survival after heart transplantation. The specific aims are:
Aim 1. Clinical trial to determine safety of belatacept in heart transplantation. We will perform a
multicenter clinical trial in EBV seropositive heart transplant recipients randomized 2:1 to receive belatacept
with gradual tacrolimus withdrawal (9-months) post-heart transplant or standard-of-care tacrolimus (control).
The objectives are to a) establish safety of the protocol based on stopping criteria defined by the composite of
historical control event rates and b) test efficacy for kidney sparing and DSA.
Aim 2. Impact of CNI withdrawal under costimulation blockade on graft-reactive immune responses.
We will serially analyze donor reactive, and autoantigen reactive T cell and B cell subsets using state-of-the-art
phenotypic and functional assays and will quantify DSA and autoantibodies. Results will be compared between
study arms and the kinetics of responses will be evaluated in individual subjects over time.
Aim 3. Other mechanistic/biomarker studies relevant to primary and secondary endpoints in the trial.
We will use molecular approaches to define differences in the intragraft response, explore markers of kidney
injury and fibrosis, and test donor derived cell-free DNA as a potential biomarker of impeding rejection during
CNI withdrawal. If successful, belatacept has the potential to transform the heart transplant field, removing
CNI-morbidities and preventing DSA as major barriers to improving long-term survival. The comprehensive
mechanistic studies will provide novel information, regardless of outcomes of the trial.

Public health relevance
Project Narrative Long-term survival after heart transplantation continues to be limited both by immune-mediated damage to the transplant and by adverse effects caused by calcineurin inhibitors (CNIs), which are part of nearly all immunosuppressive regimens in heart transplantation. In this application we propose to use belatacept, initially with a CNI that will be slowly reduced and then stopped, to achieve CNI-free immunosuppression (with mycophenolate mofetil and prednisone), which we hypothesize will prevent rejection, suppress the development of antibodies that cause damage to the transplant, and eliminate the adverse effects of CNIs together improving survival after heart transplantation. The accompanying studies will inform as to why the approach did or did not work and determine whether non-invasive biomarkers can be used to predict clinical outcomes.